Rapid non-invasive biomechanical imaging of neural crest cell migration in vivo

Project Summary
Neural crest cells (NCCs) are a highly migratory cell population that collectively migrates to various places and
involves organogenesis during embryo development. The aberrant NCC development can lead to severe
congenital and hereditary malformations and diseases. In vitro and recent in vivo evidence show the NCCs
coordinate their behaviors upon mechanical changes of external environment, suggesting the crucial
involvement of biomechanical cues. However, there are literature controversies regarding data interpretation for
implementing contact-based tool in 3D embryonic tissue where involves complex mechanical crosstalk, and it is
unknown if there exist a universal mechanical mechanism across species among which NCCs behave very
differently. One major reason is the lack of non-contact and non-invasive tool that can access 3D biomechanics
of embryonic cell and tissue with high resolution and high speed in vivo. This proposal addresses this unmet
need based on a novel optical technology named Brillouin microscopy. The goal of this project is to develop and
validate a coaxial line scanning Brillouin microscopy (c-LSBM) for rapidly acquiring mechanical images of NCCs
and surrounding tissues in vivo. Specifically, we will focus on the biomechanics during the onset of epithelial-
mesenchymal transition and the collective migration, which are crucial events for enabling the function of NCCs
in morphogenesis. To achieve this goal, we will first develop c-LSBM into an instrument, which overcomes
several technical limitations of existing Brillouin technology and allows distortion-free measurement. In addition,
the c-LSBM will be equipped with fluorescence channels for multimodal imaging, and the mechanical relevance
of acquired Brillouin data will be validated against gold-standard AFM technique (Aim 1). We will then use this
new non-invasive tool to elucidate the role of tissue biomechanics in affecting the migration behavior of NCCs in
chick embryo in vivo, which enables us to address the current literature controversies regarding how cells adapt
their stiffness to the mechanical environment (Aim 2). In summary, the c-LSBM instrument can serve as a new
tool for in-depth biomechanical studies of embryo development in vivo. The non-contact and non-invasive
characters of this Brillouin technology can provide new data to advance our knowledge of the physical aspects
of development. Together with existing tools as well as genetic & molecular analysis, this will provide a complete
methodology for investigating the developmental disorders and the prevention of birth diseases.

Public health relevance
Project Narrative Neural crest cells (NCCs) contribute to organogenesis during embryo development, and the aberrant NCCs development can lead to severe malformations and diseases. The mechanical cues of the environment affect the behavior of NCCs but are difficult to quantify due to the complex mechanical crosstalk in 3D embryonic tissue. This project will develop a new non-invasive and non-contact optical tool that can rapidly acquire mechanical images of NCCs and surrounding tissue in chick embryo in vivo, and the successful development of the new technology can provide new data to advance our knowledge of the physical aspects of development.